Pathogenesis of Nerve Injury: Role of Tissue Inhibitor of Metalloproteinases-1

Extremity (e.g., leg) trauma accounts for the majority of combat wounds and causes peripheral nerve injury.
Despite the high regenerative capacity of the peripheral nervous system (PNS), patients develop severe
sensorimotor abnormalities and neuropathic pain (NP) sustaining for years after injury. In the framework of this
VA Merit program (since 2005), we have pioneered research on tissue inhibitor of metalloproteinases (TIMP)-
1 in the PNS injury-related NP as an endogenous inhibitor of the matrix metalloproteinases (MMPs) and have
demonstrated robust pro-regenerative and analgesic activity of both synthetic MMP inhibitors (MMPi) and TIMPs
in the PNS. Given the emerging evidence for sexual dimorphism in mechanisms of PNS injury and NP, since
2020, we have focused the present study of TIMP-1 as an X-chromosome-encoded, top-induced early-
response gene in the damaged PNS. Using ground-breaking concepts and innovative tools (e.g., BioID/TIMP
constructs, TIMP1-enriched EVs, TIMP1-activating CRISPR-CAS9 system, RNAseq, LC-MS mass
spectrometry, bioinformatics), we provide the first evidence of TIMP-1’s novel and/or sex-dependent myelin
membrane MMTIMP-1 isoform and implicate TIMP-1 in sex-dependent establishment of extracellular vesicle (EV)
transport by association with chaperone, cytoskeletal and scaffolding proteins. We hypothesize that in addition
to the classical (secreted) isoform of TIMP-1 that inhibits MMPs and binds receptors, MMTIMP-1 contributes to
the sex-specific EV transport to DRG neuronal soma. We aim to establish Schwann cell (Aim 1) and sensory
neuronal (Aim 2) functions of the classical (secreted), MMTIMP-1 and intracellular TIMP-1 isoforms in exosome
formation and sex-specific neurotrophic, neuroprotective and anti-apoptotic activities. We are eager to continue
this trailblazing work, aiming to ultimately develop a novel non-addictive, neuroprotective, regenerative and
analgesic TIMP1-containing EV and/or neuron-targeted TIMP-1 gene therapy (Aim 3).

Public health relevance
Extremity trauma causing nerve injury accounts for the majority of combat wounds and results in chronic nerve (termed neuropathic) pain. Effective nerve repair is necessary to prevent the development of neuropathic pain. Tissue inhibitor of metalloproteinase (TIMP) proteins control nerve regrowth and pain development and this control point may be genetically and epigenetically linked to sex chromosomes.